GamerFit: A Digital Intervention to Improve Physical Activity and Sleep Behaviors in Youth with Psychiatric Diagnoses

Project Summary
More than 1 in 4 children receive at least one psychiatric diagnosis (PD) before age 17. These youth face
significantly elevated chronic disease risk including high prevalence of obesity, which is propelled by low
physical activity (PA) levels, poor sleep, and social isolation. Unhealthy PA and sleep behaviors not only
increase preventable chronic disease risks, they also worsen the cognitive and behavioral functioning
challenges these youth experience. The goal of “GamerFit” is to test the delivery of a theory-based mHealth
app that utilizes social support, exergaming, and telehealth coaching to improve PA levels, sleep, and
psychiatric symptoms among youth participants (ages 14-17 y) with PD. In order to aid future intervention
optimization, we will randomize 60 participants with at least one PD, with 30 using the GamerFit app with
weekly telehealth coaching sessions and 30 using a commercial healthy habits app as a comparator group.
The GamerFit app will provide access to a menu of exergames, progressive PA and sleep plan, integrated self-
monitoring, pre-recorded videos addressing healthy PA and sleep habits, and motivational text messages to
help users meet PA and sleep guidelines over 12 weeks. The project leverages our pilot data on exergaming
and telehealth coaching to improve PA in youth with PD, and our interdisciplinary team has expertise in
developmental psychology, PA and sleep intervention design, technology-based health promotion, and app
development. The major research question is: Is a 12-week exergaming and telehealth coaching intervention,
delivered via a smartphone app, an acceptable, feasible and effective method to improve PA and sleep
behaviors in youth with PD? The specific aims are as follows: Specific Aim 1: To examine feasibility and
acceptability of the 12-week GamerFit intervention delivered through a mobile app to youth with PD and their
parents. Specific Aim 2: To test the hypothesis that the 12-week GamerFit intervention delivered through a
mobile app will improve PA levels and sleep quality and duration compared to a comparator group that uses an
unstructured healthy habits tracking app. Exploratory Aims: To test the hypothesis that the 12-week GamerFit
intervention delivered through a mobile app will improve mood, behavioral regulation, and perceived social
isolation and support compared to the comparator group; and to test the hypothesis that behavioral effects will
be sustained at week 16 (i.e. 4-weeks after the end of the intervention). We will also work with clinicians to
explore approaches to incorporating the app, specifically PA prescriptions, into psychiatric treatment plans.
This project impacts the field by testing the delivery of a theory- and evidence-based exergaming and
telehealth coaching intervention targeting multiple health behaviors in youth with PD via a low-cost app.

Public health relevance
Project Narrative Increasing physical activity and sleep levels in youth with psychiatric diagnoses has been shown to improve cognitive and behavioral function, as well as reduce risk of obesity and other chronic diseases. The goal of “GamerFit” is to develop and test a web-based, mobile-friendly application (app) that utilizes telehealth coaching and exergaming to improve physical activity and sleep behaviors among youth participants with psychiatric diagnoses; aims include examining if using an app to engage in physical activity and telehealth coaching is feasible and acceptable to this population and improves physical activity and sleep compared to youth using a commercially available healthy habits comparator app. As exploratory outcomes, we will also examine if participants’ mood, behavioral regulation, and perceived social support improve more in the GamerFit participants compared to the comparator group; we will also test the hypothesis that PA and sleep effects will be sustained 4-weeks after the intervention ends.